Apelin Signaling in Muscle Regeneration

Abstract: Apelin Signaling Pathway In Muscle Regeneration And Rejuvenation
PI: Madelaine Romain
How extracellular signals and cell-to-cell communication dysregulation affect tissue homeostasis during aging
are still poorly understood. The age associated muscle disease, sarcopenia, affects more than 60% of people
over 80 years of age and results in mobility disorders and a significantly increased risk of mortality. Identifying
dysregulated biological mechanisms involved in the etiology of sarcopenia is critical to develop therapeutic
treatments to limit muscle atrophy. Recently, the expression of the apelin peptide has been shown to decline
with age, correlating with an increased inflammation, senescence, and degeneration of the muscle tissue.
Interestingly, treatments with the apelin peptide improve muscle regeneration and muscular function in aged
animals, indicating a role in muscle regeneration and rejuvenation. However, the molecular and cellular
mechanisms underlying apelin function are largely unknown, and the apelin dependent cellular crosstalk
between muscle stem cells (MuSC), endothelial cells, and immune cells contributing to enhanced muscle
regeneration are uncharacterized. Using the zebrafish as a model system, we will combine novel
pharmacological genetic approaches to perform state of the art apelin loss and gain of function studies and use
single cell RNA sequencing to identify downstream effectors of apelin that limit the impacts of aging. We
propose to test the function of apelin as an anti-aging and pro-regenerative signaling peptide and decipher cell
type specific functions of apelin during muscle aging and regeneration. This COBRE project includes two
specific aims. During the first aim, we will use a recently discovered chemical agonist of the apelin receptors
and newly generated Cre/Lox zebrafish transgenic lines to determine how chronic and genetically-induced
muscle-derived apelin affects the hallmarks of muscle aging (atrophy, senescence, inflammation…). Novel
CRISPR/Cas-9 zebrafish mutants will also us allow to test the function of the apelin receptor activation in
MuSC, endothelial cells and macrophages to decipher the cell type-specific apelin functions during muscle
aging and regeneration. Using state of the art single cell RNA-sequencing, aim 2 will reveal a set of genes
regulating MuSC transition into proliferation after injury. Taking advantage of the apelin receptors mutant fish,
this transcriptomic analysis should also lead to the identification of regenerative factors underlying apelin
functions in MuSC-dependent regenerative response. Successful completion of these aims will define the role
of the apelin signaling in multiple different cell types during muscle aging and reveal molecular and cellular
therapeutic targets to alleviate or reverse age-associated sarcopenia.